SOLUTION CONFORMATIONAL DYNAMICS OF RIBOSOMEL PROTEIN 1 7 &1 12

Analysis of dendrin based MRI contrast agents targeting the affinity for receptor round on tumors of epithelial origin. IR dyes will be monitored at the LFD as they accumulate in tumors grown in rats or in mice.